RETRIEVAL FROM FULL-TEXT MEDICAL DATABASES

This proposal advocates a continuation of the MEDLINE/Full-Text Research Project which has studied aspects of the retrieval of relevant articles from full-text databases. In carrying out this phase of the project we shall make extensive use of the data which we have accumulated in answering previous research questions. Two of the four new questions to be addressed arise directly from the results of the current quest for heuristics for full-text searching. They are: 1) How many times should a searcher request that a given concept appear in a document--and in which fields--in order to insure optimum retrieval? 2) What effect does the ability to search both the indexing and the natural language of full-text have on retrieval? The third question results from the increasing use of the structured abstract in medical journals; it is, 3) Does the full-text retain its recall advantage now that the structured abstract is available in the bibliographic files? This question arises from the possibility that the structured abstract might be sufficient for retrieval since it covers certain variables which would be of importance in a search. The fourth question has been suggested by physician participants in the project and focusses our search for heuristics on specific types of relevant articles. It is: 4) How can the searcher of full-text manipulate the strategy to retrieve only relevant articles of highest quality? A corollary questions arises: if quality filters are applied to retrieval from full-text databases does the advantage of full-text over MEDLINE remain? The advent of new searching software for full-text in both online systems and CD-ROM products now makes it possible to investigate the first two questions. Data accumulated so far suggests that there is a close relationship between kind of concept being searched and the most effective search heuristic. By repeating a search in both MEDLINE with the structured abstract and in a full-text journal file-we should be able to see if the full-text retains its recall advantage. Finally the obvious need for "quality filters" in medical information retrieval is the impetus for a search for heuristics for the retrieval of the "best" in full-text medical literature.